REORGANIZATION OF ACTIVITY IN THE GUSTATORY CORTEX

The loss of the ability to smell and taste occurs often and has strong, adverse effects on human behavior, often resulting in long lasting depression. Studying how taste is perceived might aide in preventing the loss of this sensory modality. The aim of this proposal is to describe the hamster gustatory cortex, determine how sensory inputs are organized in this area, and determine the afferent and efferent projections of this area. The first objective will be to describe where lingual and extra-lingual stimuli are represented in the cortex. Chemical stimuli will be applied to one of the following: the anterior or posterior tongue, the soft palate and the epiglottal taste area. The hypothesis being tested is: There is an orotopic map in the gustatory cortex of the hamster. A second corollary hypothesis is: There is a cortical area which becomes active when the epiglottal taste area is activated. The second objective will be to examine connections between the gustatory cortex and other brain areas. First, an area will be electrophysiologically confirmed as gustatory and second, will be injected with either an anterograde or retrograde tract tracer. One hypothesis that will be tested is: Is there a topographic map of the parabrachial nucleus in the gustatory cortex? The third objective will be to determine how specific stimuli are encoded in the gustatory cortex. Specific chemical stimuli tactile and thermal stimuli will be applied to each lingual and non-lingual taste area where possible, the activity recorded with single unit electrodes and the location of these units recorded. The hypothesis tested is: There is a chemotropic map within each orotopic representation in the gustatory cortex.